ThymUS 2025 International Conference on Lymphopoiesis

PROJECT SUMMARY/ABSTRACT
The ThymUS 2025 International Conference on Lymphopoiesis, T cell Differentiation and Immune Reconstitution
(http://sites.google.com/thymusmeeting.org/thymus2025/home) will be held at the Royal Sonesta Hotel in Lihue,
HI from April 27-May2, 2025. This is the seventh iteration of the conference, which is the only US-based meeting
specifically dedicated to the topic of the thymus and T lymphocyte differentiation, and how these processes are
altered during aging and by disease. The conference therefore has a unique scientific content, addressing the
highly dynamic and prolific field of adaptive immunity, thymus organogenesis, and T cell development and
differentiation, and is relevant for resistance to infection, immune homeostasis from birth to aging, immune
reconstitution after therapeutic or pathologic T cell ablation, self-tolerance, and autoimmunity. Importantly, the
conference provides several unparalleled features, including (i) a singular focus on thymus biology, which is
unique in the Americas; (ii) low cost to all attendees, with additional subsidies provided to trainees; (iii) an
extremely rich array of unbiased presentation opportunities, with special attention to trainees; and (iv) a highly
stimulating informal interactive environment, providing trainees with access to leaders in the field for the duration
of the conference.

Public health relevance
PROJECT NARRATIVE/HEALTH RELEVANCE This conference will promote the vigorous exchange of scientific information and highlight relevant therapeutic advances in thymus biology between US, European, Australian and Asian scientists, and will enable trainees to display their research to, and advance their careers in contact with, senior scientists from these countries. This will lead to new insights into the mechanistic bases for immunity to infection, autoimmunity, and immune tolerance in cancer.